Non-invasive abdominal fetal electroencephalography for fetal assessment

ABSTRACT
Every year in the United States, over 35,000 newborns suffer from neurologic injury at the time of birth due to
hypoxia. Despite widespread use of cardiac external fetal monitoring (EFM) for the last 60 years, the rate of fetal
neurologic injury has not decreased, highlighting the urgent need for better assessment methods in labor.
Currently, clinicians still rely on cardiac EFM, which reflects a downstream effect of initial neurologic damage
due to interruptions in fetal oxygenation resulting in subsequent heart rate changes. Relying on downstream
effects can be inaccurate and result in both false positive and false negative diagnoses. Evaluating fetal brain
activity via fetal electroencephalography (fEEG) has been shown to be a promising method as it shows abrupt
signal changes up to ten minutes before cardiac EFM changes measured in fetuses with acidemia. These ten
minutes in delivering a fetus can be the difference between lifelong cerebral palsy and a developmentally normal
child. However, vaginal fetal EEG (V-fEEG), the only currently available method, is invasive, requiring vaginal
electrodes attached to the fetal scalp. Consequently, it has been abandoned as a monitoring method. Non-
computerized abdominal fetal EEG, which is non-invasive, has been proposed, but is uninterpretable due to
extensive signal artifact from non-EEG signals from the abdomen due to maternal and fetal movement, muscle
activity, and maternal and fetal electrocardiogram signal. Our work overcomes this challenge by harnessing
advances in artificial intelligence to identify and filter out non-fetal EEG signals, allowing fetal neurologic activity
to be accurately and non-invasively measured. We have developed an algorithm that has been refined and
applied to patients that shows classical fetal EEG response to auditory stimuli, or evoked brain stem potentials.
Using this algorithm, fetal EEG signals can be separated cleanly from maternal and other fetal noise. Our
hypothesis is that our method of computerized abdominal fetal EEG (cAb-fEEG) can rapidly and accurately
reconstruct fetal neurologic activity and is equivalent to invasive V-fEEG monitoring. To test this hypothesis, we
will first compare our method of cAb-fEEG to direct V-fEEG in a group of 46 patients to quantify reconstruction
error (regression residuals) between the signals. Second, neurology clinical experts in EEG interpretation will
evaluate the neurological features of both cAb-fEEG and V-fEEG. To achieve these aims, we have assembled
and will lead a team of experts in EEG research, electrical and computational engineering, clinical neurology,
obstetrics, and pediatrics. We expect the results of this study will formally provide a strong base for cAb-fEEG
and lay the foundation for future clinical studies to evaluate cAb-fEEG as a monitoring method to improve
perinatal outcomes. The results of this research will provide a non-invasive and novel method to directly measure
fetal neurologic activity and have the potential to decrease the rates of preventable brain injury at birth.

Public health relevance
PROJECT NARRATIVE This proposal seeks to validate the first transabdominal, non-invasive fetal electroencephalogram (EEG) using data collected from fetal scalp electrodes during active labor. The system employs a novel artificial intelligence approach to reconstruct fetal EEG from electrophysiological signals collected from the maternal abdomen. Successful validation of this system has the potential of transforming fetal monitoring and brain development research in humans.